Angiotensin-(1-7) and beta adrenergic receptor signaling in aging

PROJECT SUMMARY
Aging is an independent risk factor for developing hypertension and cardiovascular disease. An important
hallmark of aging is increased sympathetic nervous system activity, which can decrease vascular β2
adrenergic receptors (β2AR) to reduce nitric oxide (NO)-dependent vasodilation and increase blood pressure.
Accumulating evidence from our laboratory suggests that deficiency of angiotensin (Ang)-(1-7), a protective
hormone of the renin-angiotensin system, provides an important link to connect aging with sympathetic
overactivation and hypertension. In support of this, we have shown that aging mice exhibit circulating Ang-(1-7)
deficiency, and chronic restoration of Ang-(1-7) lowers cardiac and vascular sympathetic tone and blood
pressure in this model. Our preliminary data translate these findings to show that circulating Ang-(1-7) levels
are similarly reduced in older healthy humans, with acute Ang-(1-7) restoration tending to decrease cardiac
sympathetic tone and blood pressure and increase endothelial-dependent vasodilation. Importantly, our
preliminary data provide evidence that cardioprotective effects of Ang-(1-7) in aging require activation of β2AR-
signaling. We show that chronic Ang-(1-7) treatment selectively increases β2AR gene expression in
mesenteric vessels from aging mice, and depressor effects of Ang-(1-7) are prevented by β2AR antagonism.
Based on these data, this proposal will test the central hypothesis that Ang-(1-7) reduces sympathetic outflow
to restore vascular β2AR-NO signaling and lower blood pressure in aging. Aim 1 will determine if acute Ang-(1-
7) infusion decreases sympathetic tone in older healthy humans, and if these effects are associated with
increased endothelial-dependent vasodilation and reduced blood pressure. Aim 2 will determine if in vivo Ang-
(1-7) treatment increases β2AR-NO signaling pathways in mesenteric arteries from aging mice and endothelial
cells from older healthy humans. We will determine potential cellular mechanisms by which Ang-(1-7) interacts
with adrenergic-vascular signaling in aging using RNA sequencing to guide future studies. Aim 3 will determine
the vascular cell-specific site of action for depressor effects of Ang-(1-7) using genetically modified mouse
models with deletion of β2AR in endothelial versus vascular smooth muscle cells. Aim 4 will determine if
therapies blocking Ang II activity reduce sympathetic tone and blood pressure by activating endogenous Ang-
(1-7) pathways. Overall, this proposal will capitalize on in vivo and in vitro techniques spanning the cellular to
preclinical to clinical levels to determine the functional importance of adrenergic-vascular mechanisms to Ang-
(1-7) cardiovascular actions in aging. These studies also have the potential to inform on whether Ang-(1-7)
represents a novel therapeutic target for age-related cardiovascular disease. These studies logically build upon
the PI’s translational background in integrative animal and clinical methods to assess cardiovascular
autonomic regulation, will allow her to develop a new skillset in advanced molecular biology methods, and will
provide strong mentorship and a research framework to establish an independent and novel area of research.

Public health relevance
PROJECT NARRATIVE Aging is an independent risk factor for developing high blood pressure and cardiovascular disease, but the underlying mechanisms remain poorly understood. This proposal will determine if the protective hormone angiotensin-(1-7) can lower blood pressure during aging by reducing excessive sympathetic nervous system outflow to restore the ability of β2-adrenergic receptors to dilate blood vessels. These studies will advance our understanding of mechanisms contributing to increased blood pressure during aging, as well as inform on the potential for targeting angiotensin-(1-7) to improve age-related cardiovascular risk.